7/7-Collaborative genomic studies of Tourette Disorder

PROJECT SUMMARY
Despite strong evidence for a genetic contribution to Tourette disorder (TD), progress in the identification of
specific risk genes has been, until quite recently, halting. However, building upon NIMH's support for our initial
efforts to ascertain TD trios as well as our highly successful experience with genomic investigations of autism
spectrum disorders (ASD), we have now demonstrated a clear path forward for reliable, systematic gene
discovery in TD. Our TD work, recently published in the journal Neuron, identified one high confidence and three
probable novel TD risk genes collectively pointing to neurite outgrowth and axon pathfinding as potential
pathological mechanisms1. More importantly, however, our findings demonstrate, for the first time, a clear excess
of de novo damaging point mutations in individuals with TD, with effect sizes that rival our recent findings in ASD.
This discovery strongly suggests that sequencing of larger cohorts will reliably and rapidly lead to the
identification of many more highly penetrant risk genes. Moreover, our recent work suggests an increased yield
of highly penetrant damaging de novo variants in probands who are affected both with TD and obsessive
compulsive disorder or attention deficit hyperactivity disorder, suggesting that our efforts may well also offer
avenues to study the overlap in genetic risks for these often-comorbid conditions. Our current application
proposes to: (1) expand our well characterized TD trio cohort by an additional 1,000 simplex trios and make the
phenotypic data and biological materials widely and rapidly available to the broad scientific community; (2)
accelerate gene discovery, via genotyping (for large de novo CNV identification) and whole exome sequencing
(for de novo single nucleotide variant, insertion/deletion variant, and small CNV identification) of these additional
TD trios, making these data rapidly and widely available as well; (3) extend the process of in silico and in vitro
genomics investigations to elaborate the biology of TD with the long term goal of developing novel and more
effective treatment strategies; and (4) begin biological characterization of TD variants using iPSC-derived
neuronal cells. Given the potentially debilitating nature of TD alone, and a population prevalence of
approximately 1 in 100 individuals, such advances would confer a significant public health benefit. The study
design again rests heavily on the collaborative R01 mechanism that will bring together deep experience with the
TD phenotype at multiple sites across the globe with scientists with a strong track record of success in rare
variant human genomics and gene discovery. Specifically, the proposal includes seven primary US sites, four
direct subcontracts (two USA sites for clinical supervision and data analysis and two foreign coordinating sites),
and fourteen secondary clinical sites within Europe and South Korea.

Public health relevance
PROJECT NARRATIVE Tourette disorder (TD) is a poorly understood, often debilitating developmental neuropsychiatric disorder, characterized by a combination of persistent vocal and motor tics, affecting between 0.3 to 1% of people worldwide. Our international team of collaborating clinicians and geneticists has established the contribution of new (de novo) variants to TD risk and demonstrated that the continued identification of recurrent de novo variants, via sequencing of the protein coding segment of the genome, is a reliable, systematic path forward for gene discovery. Therefore, our group plans to recruit 1,000 additional parent-child simplex trios, sequence these families, identify additional high confidence TD genes, and begin the process of leveraging these molecular clues to elaborate the biological basis of TD, while making all the collected biomaterials, clinical and genomic data rapidly available to the broad scientific community.